Regional Fatty Acid Metabolism In Humans

Project Summary/Abstract
The long-term goal of our research is to understand how obesity, specifically upper body obesity
(UBO), causes insulin resistance and the other health problems such as Type 2 Diabetes. Our focus has been
on how free fatty acid (FFA) release from adipose tissue lipolysis in humans affect the functioning of other
tissues (lipotoxicity). The specific aims of this proposal are to: 1) determine whether insulin-resistant UBO have
reduced muscle glucose uptake in response to exercise compared with insulin sensitive normal weight control
volunteers; 2) assess whether the exercise signaling pathway is intact in insulin-resistant UBO compared with
insulin sensitive normal weight control volunteers; 3) measure whether the trafficking of plasma FFA-palmitate
into lipid intermediates is altered in insulin resistant UBO compared with insulin sensitive, normal weight control
volunteers; and 4) determine whether overnight, modest increases in plasma FFA using an intra-duodenal
palm oil infusion impairs exercise-stimulated muscle glucose uptake in insulin sensitive, normal weight
volunteers. We will measure exercise-stimulated muscle glucose uptake in vivo and assess some of the
muscle signaling proteins involved in GLUT4 translocation in insulin sensitive lean and insulin resistant UBO
that are matched for fitness. We will also measure whether raising FFA in a physiological pattern using palm
oil reduces exercise-stimulated muscle glucose uptake. Our hypothesis is that the distal steps involved in
muscle glucose transport are altered in UBO humans (e.g. exercise-stimulated muscle glucose uptake is also
impaired in UBO) and that these defects are responsible for the apparent insulin resistance with regards to
muscle glucose uptake. Combined, we believe these studies will offer insights as to why UBO are insulin
resistant and provide information on what therapeutic strategies to treat muscle insulin resistance are most
promising.

Public health relevance
Project Narrative We wish to understand why people who gain weight primarily in the abdominal area are more prone to illnesses such as diabetes. We know that those with excess upper body fat (upper body obesity) are unable to take up sugar normally in muscle tissue, which then effects how the rest of our body is able to metabolize sugars. The experiments we propose will measure whether exercise is able to normalize sugar uptake into muscle in adults with upper body obesity and whether increases in blood fats will reduce the ability of exercise to stimulate uptake of sugar into leg muscle.